Administrative Supplement for Equipment

NOT-GM-24-021
Parent Grant: R35-GM122483. Metal Catalyzed Methods for Organic Synthesis
Research Plan:
Our group's research focuses on developing methods for forming carbon-heteroatom and carbon-
carbon bonds. Creating highly functionalized molecules in a reliable manner is crucial for organic
synthesis, underpinning drug discovery, development, and scale-up. Our techniques are widely adopted
in academia and industry for synthesizing complex molecules, serving as important processes for
synthetic chemists. By inventing new methods, we not only gain access to important compounds but also
the ability to modify them efﬁciently and selectively, altering their properties and minimizing side effects.
Our ongoing projects encompass various areas, including palladium-catalyzed cross coupling
methods for generating heterocyclic carbon-nitrogen bonds; copper-catalyzed methods for the
construction of carbon-oxygen or carbon-nitrogen bonds; copper-catalyzed methods for the highly regio-
diastereo-, and enantioselective synthesis of aliphatic amines; and copper-catalyzed methods for the
asymmetric formation of carbon-carbon bonds. Mechanistic studies have helped us to investigate the
fundamental aspects of these transformations, guiding us to enhance their efﬁciency and applicability.
The substrates we target are integral structural components found in pharmaceuticals, natural products,
agrochemicals and sensors.
In our continued efforts in Pd-catalyzed cross coupling reactions we have developed easily
accessible precursors for Pd oxidative addition complexes.1 We have also designed new ligands and mild
reaction conditions for the C–N cross coupling of ﬁve-membered heteroaryl halides with secondary,
primary aliphatic amines and anilines.2
Ullmann-type C–N coupling reactions represent an important alternative to well-established
palladium-catalyzed approaches due to the differing reactivity, lower cost, and diminished toxicity of
copper. Using a combination of experimental and theoretical methods we have established a new class
of anionic ligands for Cu-catalyzed C–N coupling of aryl bromides and alkyl amines at room temperature.3
Using our newly developed N1,N2-diarylbenzene-1,2-diamine ligand class, we have also developed a Cu-
catalyzed method for the coupling of alcohols and (hetero)aryl bromides.4
We have introduced new copper-hydride methods for the enantioselective oleﬁn
hydromethylation,5 alkyne hydroalkylation,6 and the asymmetric formal hydroformylation of vinyl arenes.7
Since the submission of our last renewal in 2022, we have reported 14 publications that were
funded by the parent grant R35-122483. We dedicate signiﬁcant efforts to make our methods user-
friendly, practical, and applicable across a broad spectrum of compounds. We systematically optimize
the limitations and range of conditions and substrates they can accommodate. Several analytical
instruments play important roles in our studies including, nuclear magnetic spectroscopy (NMR)
spectroscopy, supercritical ﬂuid chromatography (SFC), automated ﬂash column puriﬁcation system,
high-performance liquid chromatography (HPLC), infrared (IR) spectroscopy, gas chromatography (GC)
and mass spectrometry (MS).
One of the most heavily relied on tools in our lab is the GCMS. Researchers employ the GCMS
to analyze volatile reaction products, identify intermediates and quantify reactants and products. By
coupling gas chromatography with mass spectrometry, it can separate and detect compounds based on
their mass-to-charge rations. The GCMS helps in the Identiﬁcation and quantiﬁcation of reaction
components, monitoring reaction progress, elucidation of reaction mechanisms, characterization of
intermediates, analysis of catalyst stability and deactivation, and reaction optimization. It is a powerful
analytical technique that enables us to explore the intricacies of catalytic systems and its impact.
Our current instrument is an Agilent GC model 6850 and MS model 5975 system. It was acquired
in 2006 and has undergone numerous repairs to address a range of issues. Just since 2020, we have
spent $15,000 in repairs and services. At this point, it is so outdated that Agilent can no longer offer us
repair options or service contracts for this system. It is essential to our work and used daily by researchers
in our lab. The duration of downtime resulting from these repairs has varied, spanning from a day to
several weeks, contingent upon the complexity of the issue, technician availability and awaiting
replacement parts.
During method development, GCMS is used to analyze reaction mixtures, aiding in the
identiﬁcation of starting materials, intermediates, by-products, and ﬁnal products generated. By
comparing the mass spectra and retention times with authentic standards, we can identify and quantify
each component which helps us to assess the efﬁciency and selectivity of the reaction.
By analyzing samples at different time points, GCMS allows for the monitoring of reaction
progress. We can see the consumption of starting materials and formation of products over time. It can
possibly also help to identify side reactions or undesirable decomposition pathways. In this manner, we
can adjust the reaction conditions such as temperature, solvent, catalyst loading and reaction times for
optimization.
In combination with other analytical tools, we can use GCMS data to elucidate reaction
mechanisms. Analysis of reaction products, isotopic labeling studies and reaction kinetics would provide
insight into plausible mechanistic pathways. Understanding of the fundamental reaction mechanism is
essential for the rational design of new ligands and catalyst systems and predicting outcomes in related
transformations.
A GCMS plays a pivotal role in our research and development of new organometallic-catalyzed
methodology by enabling the identiﬁcation, quantiﬁcation, monitoring, mechanistic elucidation, and
characterization of reaction components, intermediates, and catalysts. Its versatility and sensitivity make
it an indispensable tool for advancing our understanding of catalytic processes and facilitating the design
of novel catalysts for synthetic applications. A new system would help us optimize the workﬂow for all the
ongoing projects in our lab and provide comprehensive capabilities to identify diverse samples.
We plan to cover recurring costs associated with the requested GCMS system through service
contracts for regular maintenance and repairs to ensure optimal performance and longevity. We have
budgeted in the expendable supplies (i.e., gases, sample vials, syringe needles, and septa) as part of
our routine operations and consumables of our parent grant. The initial training will be provided by the
manufacturer (Agilent) as part of the installation of the instrument. Additionally, we will designate a person
to internally maintain and be responsible for regular upkeep of the GCMS system. This includes in-house
protocols for use and providing ongoing training for new users and refresher courses for existing users.
By implementing these plans, we aim to ensure long-term reliability, performance, and accessibility of
the GCMS system for our research activities.
Bibliography:
1. King, R. P.; Krska, S. W.; Buchwald, S. L. A Neophyl Palladacycle as an Air- and Thermally Stable
Precursor to Oxidative Addition Complexes. Org. Lett. 2021, 23, 7927-7932. (PMCID:
PMC9235910).
2. Reichert, E. C.; Feng, K.; Sather, A. C.; Buchwald, S. L. Pd-Catalyzed Amination of Base-Sensitive
Five-Membered Heteroaryl Halides with Aliphatic Amines. J. Am. Chem. Soc. 2023,145, 3323-3329.
(PMCID:PMC9988406)
3. Kim, S.-T.; Strauss, M. J.; Cabré, A.; Buchwald, S. L. Room-Temperature Cu-Catalyzed Amination
of Aryl Bromides Enabled by DFT-Guided Ligand Design. J. Am. Chem. Soc. 2023, 145, 6966-6975.
(PMCID:PMC10415864
4. Strauss, M.; Greaves, M.; Kim, S.-T.; Teijaro, C.; Schmidt, M.; Scola, P.; Buchwald, S. L. Room
Temperature Cu-Catalyzed Etheriﬁcation of Aryl Bromides. Angew. Chem. Int. Ed. 2024, 63,
e202400333. (PMCID:PMC11045308)
5. Dong, Y.; Shin, K.; Mai, B. K.; Liu, P.; Buchwalds, S. L. Copper Hydride-Catalyzed Enantioselective
Oleﬁn Hydromethylation. J. Am. Chem. Soc. 2022, 144, 16303-16309. (PMCID:PMC9994624)
6. Kutateladze, D. A.; Mai, B. K.; Dong, Y.; Zhang, Y.; Peng, L.; Buchwald, S. L. Stereoselective
Synthesis of Trisubstituted Alkenes via Copper Hydride-Catalyzed Alkyne Hydroalkylation. J. Am.
Chem. Soc. 2023, 145, 17557-17563. PMCID:PMC10569085
7. Garhwal, S.; Dong, Y.; Mai, B. K.; Liu, P.; Buchwald, S. L. CuH-Catalyzed Regio-and
Enantioselective Formal Hydroformylation of Vinyl Arenes. J. Am. Chem. Soc. 2024, ASAP.
https://doi.org/10.021/jacs.4c04287 (PMCID in progress).

Public health relevance
Project Narrative We seek to develop new transition metal-catalyzed methods that are general, user-friendly, and have a significant impact on the field of organic synthesis, particularly in pharmaceutical research. Our current work is focused on palladium and copper-catalyzed coupling methods for the formation of carbon-carbon and carbon-heteroatom bonds. We specialize in creating highly functionalized molecules reliably and our techniques are widely adopted in academia and industry for synthesizing complex compounds. Our research heavily relies on analytical instruments, notably the GCMS. The GCMS plays a pivotal role in analyzing reaction mixtures, monitoring progress and elucidating mechanisms. Our current GCMS system has become outdated and in need of extensive repairs, necessitating a replacement. A new GCMS system will enhance the efficiency and reliability of our research, facilitating our work in the development of new reaction methodology.